Determining modifiable factors for post-stroke Vascular Cognitive Impairment and Dementia

Vascular cognitive impairment and dementia (VCID) after stroke increases risk for death and is highly
disabling. New-onset VCID after stroke is common, affecting as many as one-third of stroke survivors. There
are currently no treatments recommended to reduce VCID risk. Interventions to reduce risk of incident VCID
after stroke are critically needed. One simple, inexpensive, accessible intervention that holds promise for VCID
prevention among stroke patients is cognitively stimulating activities (such as reading, doing crossword
puzzles, and word games). The performance of cognitively stimulating activities has been associated with
lower risk of dementia in stroke-free adults. Whether the performance of cognitively stimulating activities after
stroke reduces risk for VCID after stroke has not been elucidated. Other opportunities for practical
interventions to prevent VCID may be available in the treatment of sleep disorders. Obstructive sleep apnea
(OSA) is prevalent after stroke (~70% of stroke survivors) and disrupted sleep (more time spent in wakefulness
during periods of attempted sleep) is more common after stroke than in stroke-free adults. Both OSA and
disrupted sleep have been associated with cognitive decline in stroke-free adults, but their contribution to post-
stroke VCID remains unclear. If these sleep disorders are similarly associated with VCID among stroke
patients, other novel targets for VCID may become available. Currently, performance of cognitively stimulating
activities and screening and treatment for sleep disorders are not standard of care. In this project, we will: 1)
pool and harmonize longitudinal cohorts with repeated measures of cognition over time to quantify the
association between the performance of cognitively stimulating activities after stroke and post-stroke cognitive
decline and incident VCID. We will also leverage an established cohort of stroke participants with baseline
post-stroke polysomnography measures to: 2) evaluate the association between post-stroke OSA, assessed
by the apnea-hypopnea index and a threshold of hypoxemia, and post-stroke cognitive decline and incident
VCID over 2 years post-stroke, and 3) evaluate the association between measures of disrupted sleep,
assessed by wake after sleep onset and sleep efficiency, and post-stroke cognitive decline and incident VCID
over 2 years post-stroke. This project is innovative because it will leverage and pool longitudinal cohorts with
repeated measurements of cognition and cognitively stimulating activities. This project is significant because
it is a step towards identifying a possible simple intervention (cognitively stimulating activities) and novel
intervention targets (OSA and disrupted sleep) for post-stroke VCID.

Public health relevance
Project Narrative In the proposed research, we aim to evaluate the association between modifiable factors and post-stroke cognitive decline and Vascular Cognitive Impairment and Dementia (VCID). The proposed research may identify new intervenable targets to reduce the risk of VCID and improve health.